A Computational IMage Analysis Platform (CIMAP) for HuBMAP

Document not required, uploading PDF to remove error from internal routing system

Public health relevance
Public health significance: Brightfield histology imaging of tissues is inexpensive and commonly used by any clinical assessment all over the world. Our proposed tools will allow quantifying cell types, numbers, morphology, as well as states from brightfield histology images. Our success will empower clinicians anywhere in the world to deduce molecular understanding of single cells from brightfield tissue histology for clinical assessment.